Delivery of apoptotic neutrophils to improve angiogenesis during wound healing

PROJECT SUMMARY/ABSTRACT
Every year, millions of patients suffer from impaired wound healing due to injuries, surgeries, and
diseases, creating a significant public health and economic burden. The process of skin wound
healing involves clotting, inflammation, cell proliferation and migration, re-vascularization, and
remodeling, and often results in scarring. In diabetic patients or large wounds, insufficient
angiogenesis slows healing and worsens scarring. Attempts to deliver growth and angiogenic
factors or cells fall short of providing complete relief, and there is a critical need for new strategies
to promote angiogenesis and tissue repair during wound healing. The proposed project aims to
develop a novel therapeutic approach for improved angiogenesis during wound healing by
leveraging natural interactions of immune cells. We propose to deliver apoptotic neutrophils (AN)
within a degradable hydrogel scaffold that will induce efferocytosis and phagocytosis, respectively,
in local macrophages (Mφs), promoting their angiogenic signaling and tissue repair without
causing inflammation. In preliminary work, AN delivery in a gelatin methacrylate (GelMA)-based
hydrogel significantly enhanced angiogenesis in a murine skin wound model, both in wild type
and in diabetic mice. Furthermore, addition of AN and/or GelMA to macrophages in culture
stimulated their secretion of angiogenic growth factors. We propose here to investigate the effects
of GelMA-AN on Mφ uptake and growth factor secretion (Aim 1), and on angiogenesis and wound
healing of a full-thickness skin wound (Aim 2). This project will establish a new method to enhance
Mφ angiogenesis signaling, providing a platform for further investigation, and developing a
therapeutic intervention for improved wound healing. This proposed approach leverages the role
of immune cells and angiogenesis in wound healing, with modulation of Mφs phenotype
conversion for successful wound healing and tissue repair.

Public health relevance
PROJECT NARRATIVE Impaired angiogenesis during wound healing is a major clinical challenge in the healing of injured tissues. The goal of the proposed project is to create a new wound healing treatment that incorporates apoptotic neutrophils and hydrogels, which together will enhance angiogenic signaling in the wound environment. The work will open a new strategy to modulate the healing response following injury.